STEM CELL TRANSDUCTION OF SLF/FLT-3-LIGAND GENES BY AAV

Regulation of the earliest stem and progenitor cells is not completely understood. In this context we propose to test the hypothesis that the combination of two early acting cytokines: Steel factor (SLF) and the Flt- 3/Flk-2-ligand, which respectively utilize the tyrosine kinase receptors c-kit and Flt-3-/Flk-2 for their action is important for proliferation and self-renewal of early stem/progenitor cells. This will be done by using recombinant(r) adeno-associated virus (AAV) vectors to obtain high efficiency stable integration of the genes for the soluble and membrane- bound forms of both ligands into high purified stem/progenitor cells. The aims are to: 1) construct high titer rAAV vectors containing soluble or membrane-bound forms of the human (hu) or murine (mu) ligands with different promoters and selectable markers; 2) evaluate different phenotypic target cell populations that are highly enriched for stem and/or progenitor cells (including hu CD34+++ cord blood and marrow cells, and their subsets distinguished by CD38 and/or HLA-DR antigens and mu Sca- 1+ marrow cells) for their responsiveness to transduction by separate AAV vectors containing SLF or Flt-3/Flk-2, alone and in combination, and also to evaluate procedures necessary for optimal transduction of these cells; and 3) determine the success of the different transduction procedures and viral vectors on the different phenotypic target cell populations by utilizing a variety of in vitro and in vivo assays to assess effects on proliferation, self-renewal and differentiation of the cells. Assays in vitro include those for high proliferative potential colony forming cells (HPP-CFC), and immature and mature subsets of multipotential (CFU-GEMM), erythroid (BFU-E), granulocyte-macrophage (CFU-GM), granulocyte (CFU-G), and macrophage (CFU-M) progenitors and for long-term culture-initiating cells (LTC-IC). Assays in vivo will utilize hu-cell inoculated sublethally irradiated SCID mice and mu-cell inoculated lethally irradiated syngeneic normal mice. Self-renewal in vitro and in vivo will respectively be estimated by replating capacity of individual colonies and transfer of marrow cells from l degree to 2 degrees mouse recipients. It is anticipated that these studies will help to clarify a role for SLF and Flt-3/Flk-2- ligand in early hematopoiesis and the use of rAAV vectors for gene transduction and future gene therapy.